Structural and functional analysis of a novel class of androgen receptor antagonists

Project Summary
Title: Structural and functional analysis of a novel class of androgen receptor antagonists
Androgen deprivation therapy (ADT) and androgen receptor (AR)-targeting agents are the mainstay of
metastatic prostate cancer (PCa) treatment. However, PCa on ADT and/or AR-targeting agents usually lead to
relapse and castration-resistant prostate cancer (CRPC), which is mainly driven by AR activation under
castration conditions. Next-generation AR-targeting agents such as enzalutamide and abiraterone can inhibit
AR in CRPC but prolong the survival of CRPC patients for only about 4-5 months on average. The major
mechanism responsible for the resistance to next-generation AR-targeting agents is reactivation of AR. Novel
strategies to block the development of resistance to the current AR-targeted therapy are an urgent need and a
major drug development challenge. Existing FDA-approved AR antagonists compete with dihydrotestosterone
(DHT) for binding to the ligand binding domain (LBD) of AR, and patients eventually develop resistance to
these treatments. One approach to overcoming resistance is to develop compounds that inhibit AR in
alternative ways. We have identified a small molecule, SID 3712502, that is capable of inhibiting AR lacking
LBD. To optimize the efficacy of this new class of inhibitors, we developed structural analogues and identified
(+)-JJ-74-138 as a promising candidate. Our preliminary data suggest that (+)-JJ-74-138 is a novel AR
antagonist capable of degrading nuclear AR and inhibiting enzalutamide-resistant CRPC both in culture and in
xenograft tumors. However, it is not yet clear how AR interacts with (+)-JJ-74-138, which makes it difficult to
rationally develop more potent analogues. We propose the following 2 specific aims to define how (+)-JJ-74-
138 and its parent compound SID 3712502 bind to AR and develop new analogs with improved potency,
aqueous solubility and specificity for inhibition and degradation of nuclear AR. Aim 1 will determine how the
SID 3712502 scaffold binds to AR using cryogenic electron microscopy (cryoEM). We will purify full-length AR
(AR-FL), characterize interactions of AR-FL with SID 3712502 and (+)-JJ-74-138 for cryoEM structural analysis
of a suitable complex of AR-FL2/R1881/ARE/SID 3712502 (or (+)-JJ-74-138) using single particle methods.
Aim 2 will design, synthesize and analyze analogues of (+)-JJ-74-138, with the goal to identify small molecules
with submicromolar potency, improved aqueous solubility, and high specificity for AR-positive cells. We will
systematically prepare analogs of the lead compound(s) in iterative rounds of physicochemical improvements
and optimizations based on structure–activity relationship (SAR) analyses from in vitro and cell-based assays.
The success of this project will greatly facilitate the development of this class of novel AR antagonists for the
treatment of CRPC, including enzalutamide-resistant CRPC.

Public health relevance
Project Narrative Title: Structural and functional analysis of a novel class of androgen receptor antagonists Castration-resistant prostate cancer (CRPC) is currently incurable and is the second leading cause of cancer death in American men. Androgen-independent activation of the androgen receptor (AR) remains the major driving force leading to CRPC. Structural and functional analysis of a novel class of AR antagonists capable of inducing AR degradation in the nucleus may lead to new therapeutics for CRPC.